Unraveling the MALAT1 lncRNA-protein interaction networks that drive lung cancer metastasis

PROJECT SUMMARY/ABSTRACT
Long non-coding RNAs (lncRNAs), through interactions with RNA-binding proteins, play critical roles in
development and cellular homeostasis. Many lncRNAs are associated with cancer and disease, representing a
largely untouched pool of potential therapeutic targets. Metastasis Associated Lung Adenocarcinoma Transcript
1 (MALAT1) is a highly conserved lncRNA whose expression is associated with poor prognosis and drug-
resistance and whose activity accelerates cell proliferation and increases metastatic potential in multiple cancer
types. MALAT1 is ubiquitously expressed at high levels in many normal cell lines, and yet genetic deletion of the
transcript has no negative effects on development or viability in mice. The mechanisms of MALAT1 in both
normal and cancer cells are unclear, and a better understanding of these mechanisms would unlock the potential
of MALAT1 as a therapeutic target in the treatment of cancer. My preliminary data show that while levels of
MALAT1 transcript are lower in a lung adenocarcinoma cell line than in normal human lung airway epithelial
cells, metastatic activity of the adenocarcinoma is dependent on MALAT1: therefore high expression of MALAT1
is not sufficient to promote metastasis. I observe no differences in MALAT1 RNA structure between cell lines,
but levels of expression of many MALAT1-binding proteins increase significantly. These data strongly indicate
that proteins present in lung cancer cells are imparting pro-metastatic activity onto MALAT1. My goal is
to integrate cutting-edge sequencing and quantitative proteomics technologies with cell-based functional
approaches to understand how RNA-protein interaction networks of MALAT1 promote metastatic activity in
human lung cancers. In Aim 1, I will purify MALAT1 RNA-protein complexes (RNPs) from normal lung cells and
lung cancer cells and mechanistically detail the RNA and protein components of metastases-specific RNA-
protein interaction networks. I will express fragments of MALAT1 in lung cancer cell lines and identify sequences
sufficient to assemble RNP complexes and reprogram metastatic behavior in cell culture. In Aim 2, I will employ
RBPome-wide total and phospho-protemics, nucleic acid interactome capture, and fluorescent microscopy to
understand the signaling pathways that assemble dysfunctional MALAT1 RNPs genome- and transcriptome-
wide. Together, these experiments will identify the mechanisms by which MALAT1-protein interaction networks
promote each step of metastasis in lung cancer. I expect that this work will improve our fundamental
understanding of MALAT1, inform strategies to target MALAT1 therapeutically, and act as a framework for the
characterization of pro-metastatic lncRNA-protein complexes throughout the transcriptome. Development of
these proposed aims will lay the foundation for a successful career as a leader in a new field of cancer RBPomes.

Public health relevance
PROJECT NARRATIVE The potential of long non-coding RNAs as prognostic markers and potential therapeutic targets for the treatment of cancer has only begun to be explored. The expression level and structural conformation of the pro-metastatic long noncoding RNA MALAT1 are not significantly altered in cancer cells, but the expression of proteins that complex with MALAT1 varies dramatically. By determining how MALAT1-protein complexes drive cancer metastasis, this work will provide fundamental insights into mechanisms of cancer and reveal new strategies to therapeutically target cancer-causing long non-coding RNAs.